CE24-001, The University of Michigan Injury Prevention Center 2024-2029

The University of Michigan Injury Prevention Center is an Injury Control Research Center that benefits from the
vast educational, research, outreach, and policy resources of the University of Michigan to address the burden
of injury in Michigan and the Great Lakes Region. The U-M Injury Prevention Center conducts, translates, and
accelerates injury prevention research into practice and policy to reduce the burden of injuries across the Great
Lakes and the U.S. With over 1,000 members from over 35 institutions and faculty leadership from more than
14 departments, the Center brings together many disciplines to focus on injury prevention. The Center has 12
years of experience conducting injury prevention research, outreach, and translation, as well as educating the
next generation of injury scientists and practitioners. The Center’s vision is to continue to be a sustainable and
evolving Center that conducts research, training, education, and outreach informed by the engagement of our
diverse communities with the goals of reducing injuries and violence and improving outcomes for our region
and country.
The proposed Center is organized in three cores (Administrative Core with Research Administration, Outreach
Core with a Translation and Implementation Science Workgroup and Policy Workgroup, and Training and
Education Core) and four research projects. The Center provides the infrastructure to coordinate a
collaborative injury prevention agenda focused on the most pressing injury and violence concerns in our state
and the Great Lakes region which include NCIPC research priority areas: Adverse Childhood Experiences,
Suicide Prevention and Drug Overdose (Director’s Priorities), Transportation Safety, Older Adult Falls, Cross-
Cutting Violence Prevention, and Concussion (Traumatic Brain Injury).
The Center will continue teaching and mentoring undergraduate, graduate, and postdoctoral students, junior
faculty across disciplines, including medicine, public health, behavioral and social sciences, biostatistics,
biomechanics, epidemiology, law, criminal justice, nursing, kinesiology, and policy. We will provide outreach,
technical assistance, and consultation on translating research into practice through supportive relationships
with state health departments, local researchers, practitioners, and community stakeholders. The Center
supports the Midwest Injury Prevention Alliance, serves on The Society for Advancement of Violence and
Injury Research Council of Centers, and provides the framework for a coordinated, collaborative injury
prevention agenda serving the Great Lakes Region with active reach throughout the United States.

Public health relevance
The U-M Injury Prevention Center, representing the Great Lakes region, will reduce the burden of injury and violence for children and adults, especially those disproportionately affected. We describe a 5-year plan to sustain the efforts of our Center over the last 12 years and to enhance our activities to advance the scientific base for the prevention of violence and control of injuries, emphasize the translation, dissemination, and adoption of real-world interventions, and train and educate the next generation of injury scientists in complementary fields; all with a health equity lens.